Pathogenic Roles for Microtubule Stabilization Pathways in Alzheimers disease

Summary
The two main neuropathological hallmarks associated with Alzheimer’s disease (AD) are amyloid beta plaques
and intracellular neurofibrillary tangles comprised of hyperphosphorylated variants of the microtubule binding
protein tau. These deposits lead to abnormal cellular structure and loss of synapses, both of which strongly affect
behavior and memory. However, the pathogenic mechanisms that trigger the formation of these deposits and
early synaptic dysfunction are still poorly understood and lack of this knowledge is a hurdle for the development
of effective therapeutic strategies. Tubulin undergoes numerous post-translational modifications (PTMs) that
affect both microtubule stability and associated proteins, including tau and microtubule-dependent motors. The
tubulin de-tyrosination/tyrosination (deTyr/Tyr) cycle occurs when the C-terminal tyrosine of α-tubulin residing in
a microtubule is episodically cleaved and then returned by a tubulin-tyrosine-ligase (TTL). Importantly, de-
tyrosinated tubulin in neurons can be irreversibly converted by carboxypeptidases 1/6 to D2 tubulin by cleavage
of the penultimate amino acid of glutamic acid. This change permanently removes D2 tubulin from the cycle.
Loss of tubulin re-tyrosination and D2 tubulin accumulation are therefore hallmarks of microtubule longevity,
although their effects on synaptic function and tau hyperphosphorylation are completely unknown.
This proposal is designed to test the central hypothesis that inhibition of tubulin re-tyrosination
and/or accumulation of D2 tubulin affect synaptic microtubule dynamics and induce tau
hyperphosphorylation with severe consequences on neurotransmission. Our proposed studies are novel
and highly significant, as they will examine a new role for dysregulation of the deTyr/Tyr tubulin cycle in promoting
tau hyperphosphorylation and AD pathology in primary hippocampal neurons, mice and a human model of
familial AD. The hypothesis relies on our preliminary data showing that: 1) defects in tubulin re-tyrosination
correlate with AD progression and tau hyperphosphorylation in sporadic and familial AD; 2) loss of tubulin re-
tyrosination promotes activation of the stress sensor and tau kinase AMPK, tau hyperphosphorylation and
synaptic injury; 3) synaptic dynamic MTs play critical roles in synaptic and structural plasticity and changes in
TTL expression can affect them.
This proposal relies on a multidisciplinary effort to examine the in vitro and in vivo mechanisms by which
premature tubulin longevity may drive tau hyperphosphorylation and AD-related synaptic dysfunction. The work
has the potential to identify novel targets that may be modulated in drug therapies aimed at rescuing cognitive
decline in sporadic and familial forms of AD.

Public health relevance
Narrative Identifying missing elements in the pathogenesis of Alzheimer’s disease is necessary to develop effective treatments. Our proposal relies on a multidisciplinary effort to investigate the pathogenic potential for loss of tubulin re-tyrosination in the onset of Alzheimer’s disease and the mechanisms underlying loss of tubulin re- tyrosination-dependent induction of neurodegeneration and tau hyperphosphorylation. Our in vitro and in vivo studies will provide support for a novel theory of pathogenesis based on premature tubulin longevity in the onset of neuronal damage and have the potential to identify novel targets that may be modulated in drug therapies aimed at rescuing both sporadic and familial forms of Alzheimer’s disease.